Neuropathology Core

Project Summary – Neuropathology Core (NPC)
The Neuropathology Core (NPC) provides professional expertise for the diagnosis of tissue
obtained at autopsy from patients with dementia and from control subjects, recruited by the
Clinical Core (CC) of the Indiana Alzheimer’s Disease Research Center (IADRC). The NPC will
also provide information about pathologic data to referring physicians, patients’ family members,
and basic researchers. In addition, the NPC will be involved in providing continuing education to
physicians, researchers, technicians, and the community, about new developments emerging
from AD and related dementia research. Laboratory facilities and technical resources are
available for the collection, and storage of human CNS tissue.
Brain tissue of demented individuals is studied for diagnostic and research purposes using a
multidisciplinary approach. The NPC combines data obtained by neurohistology, and
immunohistochemistry to reveal the presence of abnormal proteins and determine their
localization through the CNS. The NPC has expanded its mission by integrating genetics with
neuropathology. Such integration is fundamental to understand disease etiology, pathogenesis
and phenotypic heterogeneity. This multidisciplinary approach is the hallmark of the IADRC’s
NPC and contributes to providing a definitive diagnosis of dementing disorders. The NPC
supports numerous national and international scientific programs, providing scientific insights
along with tissue samples from the brain library. Results from studies carried out by
investigators of the NPC are presented at national and international conferences, including the
annual Alzheimer Association International Conference (AAIC). In the study of patients with
dementia, the concept of precision medicine is best applied through the interaction of the NPC
with the CC, the Neuroimaging Core, the Genetics, Biomarker, and Biospecimen Core and the
Data Core.